Genomics Innovation Core B

The primary objective of the Core is to provide high quality, state-of-the-art, efficient and cost-effective
genomics services and resources to enable research on gene regulation. For the past six years, the Core has
offered RNAseq (transcriptome) and small RNA sequencing services to the Center for Reproductive Genomics
and the wider Cornell and NCTRI research communities under the name “RNA Sequencing Core”, recently
updated to the “Transcriptional Regulation and Expression” (TREx) Facility to reflect a widening scope of
services. All services include library generation, sequencing, and standard analysis, as well as pre- and post-
project consultation on experimental design and custom data analysis respectively. In addition to the end-to-
end, fee-for-service genomics services provided by TREx and with significant financial support from the Cornell
Provost, we have recently launched the “Genomics Innovation Hub” as an independent, collaborative
technology development lab. The Genomics Innovation Hub provides expertise and shared resources for
cutting-edge genomics applications with a focus on combinatorial indexing strategies for specialized or single-
cell readouts of epigenomics and gene expression, and will enable the use of these technologies for
reproductive research. Together, these operations will represent the Genomics Innovation Technology Core for
the Center for Reproductive Genomics.